Risk and Protective Factors for Multiracial Alcohol and Other Drug Use: A Mixed Methods Approach

Project Summary/Abstract
Multiracial young adults (individuals identifying as more than one race and between ages 18–25), report
alcohol and other drug (AOD) use rates that are higher than all other monoracial groups. A dearth of research
has examined risk and protective factors related to AOD use among multiracial individuals. The scant research
that exists has applied frameworks designed for monoracial populations to study multiracial individuals, and
few studies have found factors that are significantly related to AOD use in multiracial individuals. This study
improves upon the limited existing research by taking an approach that directly involves multiracial individuals
through sequential mixed methods to understand their AOD use. The specific aims of this study are to: (1)
conduct focus groups to establish an in-depth understanding of AOD use in multiracial young adults and (2)
build a model, informed by community input and qualitative analysis, identifying risk and protective factors
associated with AOD use in multiracial young adults and conduct a quantitative study to test the model. The
application is significant in that we will uncover factors associated with the high rates of AOD use among a
marginalized population of multiracial young adults that will inform interventions to reduce AOD-related health
disparities. It is innovative because we will utilize a mixed methods approach to systematically build a
community informed model of AOD use among multiracial young adults. The proposed study will be completed
in two integrated studies using sequential mixed methods. Study 1 will conduct 3–5 focus groups with 4–8
multiracial participants per group (n = 20–30) who will explore factors related to AOD use in multiracial young
adults through semi-structured interviews. Study 2 will utilize the themes uncovered from Study 1 to guide
measure selection and build and test a model using structural equation modeling (SEM) analysis (n = 120–
168). Findings will provide a useful framework for better understanding the disproportionately high rates of
AOD use among multiracial individuals. As aligned with the NIDA strategic plan, findings will uncover
environmental, social, and other causes of AOD use among multiracial young adults and provide information to
target interventions to treat and prevent problematic AOD use as well as reduce related health disparities
among this growing and high-risk population. The project will also provide the principal investigator vital
training and experience in mixed methodology research, grantsmanship, dissemination of findings, networking,
mentoring, and conducting ethical research. The research environment at University of Rhode Island including
office space, technology, and grant support, along with excellent sponsors and consultants with expertise in
relevant content areas and mixed methodology research, provide the ideal setting and mentorship to
successfully conduct the proposed project. This project would be vital as a research training opportunity for the
applicant’s future career as an independent academic researcher, which will involve research with
marginalized and understudied populations for which both quantitative and qualitative research are necessary.

Public health relevance
Project Narrative Health disparities related to alcohol and other drug (AOD) use among a largely growing population of multiracial young adults, are prevalent; yet, there is a dearth of research examining related risk and protective factors. The proposed project will: (1) provide essential training in the conduct of ethical research and grant management as well as networking, mixed methodology, and research dissemination that are necessary for the applicant and (2) use a sequential mixed methodology design to uncover risk and protective factors associated with AOD use among multiracial young adults. Results will inform interventions to reduce AOD- related disparities and will provide necessary training for the applicant to become an independent academic researcher at the forefront in research aimed to reduce AOD-related disparities among marginalized groups.